Translating germline-targeting HIV Env SOSIP immunization of infants: targeting bnAbs in early life

ABSTRACT – OVERALL
Despite decades of research and millions of global infections and deaths, we remain without an effective
vaccine against HIV. Traditional vaccine approaches have failed to induce broadly neutralizing antibodies
(bnAbs), crucial for protection against diverse HIV strains. The primary goal of next-generation HIV vaccines is
to stimulate B cell lineages capable of producing bnAbs. Recent successes in this realm involve structurally
designed immunogens, such as the BG505 Germline-Targeting (GT1.1) HIV Envelope SOSIP trimer, which
mimics native viral envelope structures and engages bnAb precursor lineages. While promising, achieving
bnAb responses in plasma, even at low levels, remains unachieved in the adult populations where it has been
tested.
Children living with HIV exhibit faster development and more polyclonal bnAb responses compared to adults,
suggesting the potential success of early-life vaccination strategies targeting bnAb responses. Our preclinical
studies in nonhuman primates have indicated that infant rhesus macaques more frequently develop bnAb
precursor responses following BG505 GT1.1 SOSIP trimer immunization, with robust autologous virus
neutralization and early evidence of heterologous virus neutralization in plasma. This vaccine has also shown
promise in adult human clinical trials in eliciting “on target” vaccine responses, without any safety concerns.
While the early life immune system may offer benefits to this vaccine regimen for achieving its immunologic
goals, the dosing, intervals, and potential interactions with pre-existing antibodies and other childhood vaccines
is unknown, limiting the development of an optimal infant phase 1 trial. Thus, this Program aims to design and
systematically test the optimal regimen of BG505 GT1.1 SOSIP trimer vaccine series as a safe and effective
pediatric immunogen for eliciting lifelong bnAb responses. Specific aims include: Aim 1: Determining the
optimal pediatric formulation and dose, Aim 2: Aligning immunization intervals with childhood vaccine
schedules and assessment of persistence of responses into adolescence, and Aim 3: Assessing the impact of
maternal antibodies and passive immunization with bnAbs on vaccine immunogenicity and efficacy. By
leveraging preclinical models to assess safety, regimen, and persistence into adulthood, this Program seeks to
overcome regulatory hurdles that will pave the way for optimized infant HIV vaccine trials. Successful induction
of bnAbs via early-life vaccination could revolutionize HIV prevention efforts, offering hope for a future without
the burden of the HIV epidemic.

Public health relevance
NARRATIVE - OVERALL Despite decades of research and millions of deaths from HIV, an effective vaccine remains elusive, with traditional approaches falling short. Next-generation vaccines, focused on inducing broadly neutralizing antibodies (bnAbs) by mimicking HIV's native envelope trimer that engage germline B cells of bnAb lineages, show promise, especially in early life when the immune environment may be more conducive to bnAb elicitation. This Program will define the optimal regimen of a promising B cell lineage based vaccine for administration along with standard childhood vaccines in a highly-relevant nonhuman primate model, paving the path for clinical licensure of an HIV vaccine that will achieve protection before adolescence.